Administrative Supplements for Equipment Purchases

Project Summary
Under the current NIGMS R15 research award (1R15GM147857-01), this proposal requests
supplemental equipment funds that will be used to replace an old broken Odyssey Infrared
Imaging system. The parent project focuses on the Proteolytic Regulation of Centrosome
Proteins. The requested equipment is essential for carrying out the experimental plans for
the Quantitative and Qualitative analysis of proteins successfully. The accurate
measurement of protein levels and detection of proteins in low abundance require enhanced
sensitivity and resolution. This administrative supplement fund will allow us to purchase Odyssey
M Imaging system. This new imaging system will replace a broken Odyssey Infrared scanner
and offer technical upgrades in the sensitivity and resolution of signal detection, which will serve
a critical role in the success of the parent R15 project.

Public health relevance
This application is for an administrative supplement to the parent R15 research award (1R15GM147857-01). We request supplemental funds to purchase the Odyssey M Imaging System to replace the broken scanner, which is essential for completing the parent project. The successful completion of this project will help further our knowledge of centrosome biology and cell division in humans with broad and important healthcare related to human cancers, ciliopathies, and developmental defects.